Developmental Research Program

The UCSF Breast SPORE Developmental Research Program is dedicated towards stimulating, funding, and guiding promising pilot projects in breast cancer research, with an emphasis on highly innovative ideas with real translational potential. This objective is being achieved through a flexible and closely monitored program that is highly inclusive to investigators and ideas. The Program has sought to respond rapidly to exploit new opportunities in breast cancer research.